Exploring Roles for Transcription Factor Ets1 in Sjogren's Syndrome

Abstract
This is a K18 application for a Short-term Mentored Career Enhancement Award in Dental, Oral and Craniofacial
Research for Mid-Career and Senior Investigators that focuses on identifying roles for the transcription factor
Ets1 in Sjogren’s syndrome using mouse models and genomics/bioinformatics approaches. The training com-
ponent of the proposal is designed to allow the principal investigator to become familiar with salivary gland biol-
ogy and normal function and to learn the techniques and approaches to characterize changes in the salivary
gland in response to the Sjogren’s syndrome. The research component seeks to determine if reduced levels of
Ets1 promote salivary gland inflammation and dysfunction. Ets1 is now well-established to play important roles
in other autoimmune and inflammatory diseases including lupus, rheumatoid arthritis, psoriasis, multiple sclero-
sis and others. But whether it is involved in regulating immune function in the context of Sjogren’s remains
unknown. We hypothesize that Ets1 regulates activation of B and T lymphocytes in the salivary gland similar to
its functions in spleen and lymph node and that the functions of Ets1 are needed to prevent development of
Sjogren’s symptoms. In this project, we propose to examine Ets1 expression in immune cells of the salivary
gland in NOD.B10 mice, a model of Sjogren’s syndrome, and correlate it with parameters of disease. We further
plan to examine mice lacking Ets1 for evidence of Sjogren’s symptoms including infiltrates into the salivary gland,
production of autoantibodies common in Sjogren’s and impairments of saliva production. These experiments will
help to define roles for Ets1 in regulating the local immune response in the salivary gland and establish its
potential role in Sjogren’s pathology. The mentor and co-mentor of this proposal will contribute by training the
applicant in methods needed for assessing salivary gland function and pathogenesis and in the use of single-
cell RNA-sequencing to identify changes in the cellular composition of the salivary gland and the transcriptome
of those cells. Both the mentor and co-mentor are experts in salivary gland biology and have expertise in the
techniques to be used in this project. This laboratory training will be complemented by seminars and meetings
in the field of salivary gland biology and Sjogren’s disease. In sum, this training opportunity will serve as a strong
foundation for future Sjogren’s disease research in the laboratory of the PI.

Public health relevance
This application is relevant to public health because it seeks to understand the pathogenesis of the autoimmune disease Sjogren’s syndrome and the particular role of a transcription factor called Ets1 in this process. Sjogren’s syndrome is a common autoimmune disease characterized by dry mouth and dry eyes and it can cause signifi- cant patient discomfort and lead to secondary effects on taste, swallowing, chewing and vision. A better under- standing the molecular mechanisms of Sjogren’s disease will help to identify novel therapeutic targets, which could be the focus of innovative approaches to regulate the immune response.